The Regulation of Macropinocytosis

Abstract:
Macropinosomes are relatively large endocytic vesicles which form in nearly all growing
metazoan cells by movements of plasma membrane and the actin cytoskeleton, and which
deliver extracellular solutes into lysosomes by microtubule-dependent membrane fusion
reactions. Macropinocytosis is the route by which many pathogenic bacteria and viruses invade
host cells, antigen is sampled for initiation of immune responses, and extracellular nutrients are
ingested to support the growth of K-Ras-transformed cancer cells. Research in the Swanson lab
has introduced foundational concepts about macropinocytosis, including how membrane
phospholipid-modifying enzymes and cytoskeletal activities coordinate macropinosome
formation, how macropinosomes transmit growth signals from cell surface receptors to the
mechanistic target of rapamycin complex-1 (mTORC1) on lysosomal membranes, and how
macropinocytosis limits damage to lysosomal membranes in activated macrophages. Despite
the recognized importance of macropinocytosis in health and disease, and the considerable
progress in understanding its mechanism and regulation, significant questions remain
unanswered: (1) How does type 1 phosphatidylinositol 3-kinase organize macropinocytic cup
closure into macropinosomes? (2) How do Src-family kinases regulate macropinocytosis? (3)
What molecules or activities determine whether macropinosomes deliver their solute contents
into lysosomes or recycle them to the cell surface? (4) How does cellular nutrient status
influence solute accumulation by macropinocytosis? This research program uses innovative
approaches to cell biology, molecular genetics and quantitative microscopy to answer these
fundamental questions. The continuation of this research will put macropinocytosis into the
context of cell growth, metabolism and innate immunity, and could lead to new therapeutic
approaches to cancer, infectious diseases and disorders of the immune system.

Public health relevance
Narrative Macropinocytosis is the cellular engulfment of extracellular fluid solutes into large vesicles called macropinosomes. Despite the demonstrated importance of macropinocytosis for human health and disease, fundamental questions remain about how macropinosomes form and function in cells. This research program will put macropinocytosis into the context of cell metabolism, and could lead to new therapeutic approaches to cancer, infectious diseases and disorders of the immune system.